Phase 1/2 trial of PEP-CMV + nivolumab for newly diagnosed diffuse midline glioma/high-grade glioma and recurrent diffuse midline glioma/high-grade glioma, medulloblastoma, and ependymoma (PRiME II)

Abstract
Brain tumors are the most common cause of cancer death in patients aged 0-19 and treatment advances
are elusive. Pediatric high-grade glioma (HGG), diffuse midline glioma (DMG), recurrent medulloblastoma
(MB), and recurrent ependymoma (EPN) are devastating diseases. The median overall survival (OS) of these
diagnoses are less than 15 months. Current treatments for these malignant tumors typically entail surgical
resection or biopsy, radiation, and sometimes chemotherapy.
Pediatric HGG, DMG, MB and EPN express human cytomegalovirus (CMV) proteins that are not found in
normal brain, thereby providing unique immunotherapeutic targets. Our group has developed a peptide vaccine
(PEP-CMV) directed to the CMV antigen, pp65. Results from a recently completed Phase I clinical trial
(PRiME, NCT03299309) of 42 patients age 3-35 with recurrent HGG/DMG and MB demonstrated significant
antigen-specific T cell immune responses to pp65 and prolonged clinical/imaging responses in many patients.
Importantly, PEP-CMV was well tolerated with only 3 Grade 3/4 adverse events. In PRiME, increased immune
response to PEP-CMV and favorable baseline immune status (low percentage of immunosuppressive Tregs and
high percentage of terminally differentiated cytotoxic T cells [TEMRAs]) were associated with better survival.
The addition of checkpoint blockade such as anti-PD-1 therapies has not been explored in
immunotherapies targeting CMV, however, it has enhanced the immunogenicity of cancer vaccines in
preclinical brain tumor models and other non-brain solid tumors. Anti-PD-1 agents also decrease Tregs and
increase TEMRA percentages. Given this, our hypotheses are that 1) the combination of PEP-CMV plus
checkpoint blockade will be safe and feasible for the treatment of DMG, HGG, MB, and EPN, 2) the addition of
checkpoint blockade will enhance the immunogenicity and effectiveness of PEP-CMV thereby improving
survival (compared to PRiME), 3) patients with newly diagnosed DMG/HGG will have significantly more robust
immune responses that patients with recurrent DMG/HGG, and 4) PEP-CMV plus checkpoint blockade will
produce an antigen-specific response in patients with EPN.
Our primary objective is to perform a multi-institutional Phase I/II trial to evaluate the safety, clinical
efficacy, and immunogenicity of PEP-CMV plus checkpoint blockade in patients aged 3-35 with recurrent DMG,
HGG, MB, or EPN or newly diagnosed DMG and HGG. To attain this objective, the following specific aims will
be pursued: Aim 1: Establish the safety and feasibility of PEP-CMV in combination with checkpoint blockade
for the treatment of patients with DMG, HGG, MB, or EPN. Aim 2: Determine the clinical outcomes of patients
who receive PEP-CMV plus checkpoint blockade. Aim 3: Assess the immunogenicity of PEP-CMV plus
checkpoint blockade in patients.

Public health relevance
Project Narrative The most common malignant pediatric brain tumors, high grade glioma, diffuse midline glioma, medulloblastoma, and ependymoma are frequently incurable. This project proposes a multi-institutional Phase 1/2 clinical trial of a peptide vaccine targeting human cytomegalovirus antigen, pp65, in combination with checkpoint blockade to treat malignant pediatric brain tumors. This combined immunotherapeutic approach has the potential to radically change how these tumors are treated by improving survival while avoiding toxicity from chemotherapy and radiation.